Genetic dissection of motivational drive to eat

Project Summary
Food intake can be triggered by not only the need for calories but also the need for specific nutrients or
need-independent mechanisms (e.g., hedonic factors, social experience, stress, etc.). Studies over the
recent decades have made substantial progress in our understanding of neural pathways controlling
food intake in the context of energy homeostasis. In contrast, there is a profound gap in our
understanding of mechanisms governing calorie-independent feeding. Using protein-specific appetite in
Drosophila as a model system, our lab seeks to understand how specific nutritional needs and need-
independent mechanisms give rise to appetites. In this proposed study, we will characterize the circuit
and molecular substrates composing the negative feedback loop during the homeostatic regulation of
protein specific appetite, as well as its coordination with other types of hunger. We also plan to
investigate two aspects of need-independent mechanisms controlling feeding, including how blue light
and social isolation impact food choice. To achieve these goals, we will employ a multidisciplinary
approach including large-scale genetic analyses, quantitative behavioral measurements,
immunohistochemistry, lipidomics analyses, stable isotope ratio mass spectrometry, functional imaging,
and patch-clamp electrophysiology. Together these investigations will substantially deepen our
understanding of calorie-independent motivational drive to eat, shedding light on the fundamental
principles for the organization and modulation of feeding behaviors.

Public health relevance
Project Narrative Food intake can be triggered not only by hunger for calories, but also by deficiencies for specific nutrients, or by need-independent mechanisms. In this proposed study, I will characterize mechanisms governing the homeostatic regulation of protein specific appetite, investigate its coordination with other types of hunger, and elucidate how environmental blue light and social isolation alters food choice. This study will provide novel insights into calorie-independent regulation of feeding behaviors.